Preventing spike-wave epileptogenesis: critical periods & neuroimaging biomarkers

In normal development there are critical periods during which learning and plasticity are enhanced. We recently found that treatment of a rodent epilepsy model with anti-seizure medication early in life, led to long-term suppression of spike-wave seizures in adulthood even after the medication was stopped. Our previous work in this rodent model demonstrated that spike-wave seizures are associated with abnormal function and structure in specific corticothalamic networks, and that these abnormalities are not present early in life before the development of seizures. Based on this, we now hypothesize that treatment early in development suppresses spike-wave epileptogenesis, and can prevent the long-term abnormalities in brain structure and function in this disorder. To translate this work into the human arena, it will be crucial to identify safe noninvasive methods to monitor biomarkers of epilepsy development in children and its prevention by therapy. Powerful neuroimaging methods now enable the noninvasive assessment of brain function and structure. Our preliminary studies have found abnormally increased resting functional connectivity on fMRI, and abnormally reduced white matter fractional anisotropy on diffusion tensor imaging (DTI) in the rodent spike-wave epilepsy model. Therefore, our aims are now to investigate fMRI resting functional connectivity and DTI as promising biomarker of epileptogenesis and its prevention by therapy. Will performing measurements of fMRI resting functional connectivity at different developmental stages in treated vs. untreated animals. We will also relate these measurements to connectivity evaluated through coherence analysis of electroencephalography. In addition, we will investigate DTI as another promising biomarker by again performing measurements at different ages in treated vs. untreated animals. We will also investigate the anatomical basis of white matter DTI abnormalities through electron microscopy to determine changes in axons and myelin in affected regions. 2.

Public health relevance
RELEVANCE: As the genetic knowledge of epilepsy grows, primary prevention will soon be a realistic goal. Detailed study of a genetic animal model in which epilepsy can be prevented will provide proof-of-principle information to guide human treatment trials. In addition, the use of neuroimaging to track the development of epilepsy will help in understanding the mechanisms of epileptogenesis, and can identify biomarkers for use in monitoring the effectiveness of human therapeutic trials designed to prevent the development of epilepsy.